Tracking and Evaluation Core

Abstract/Summary
The goal of the Tracking and Evaluation Core (TEC) of the Hispanic Alliance for Clinical and Translational
Research (Alliance) is to implement robust and exemplary practices, methods, and standards in evaluation to
strengthen Alliance capacity and performance. The objectives of TEC are to: 1) assess the Alliance
operational structure; 2) evaluate the impact of clinical and translational research of Alliance supported
research; 3) evaluate community participation and integration into Alliance activities; and 4) assess the budget,
use, quality, experiences, and impact of the Alliance resources and activities. TEC will build high evaluation
capacity in Alliance partnering institutions by integrating the Participatory and Utilization Evaluation Approach,
Continuous Quality Improvement (CQI) frameworks, and Organizational Development Initiatives through
actively involving stakeholders in the proposed monitoring and evaluation activities.
The Specific Aims of TEC are to: 1) conduct a comprehensive internal evaluation plan for assessing
progress on Alliance short-term and long-term goals; 2) integrate mixed research methods and innovative
approaches to track and monitor Alliance management, activities, resources and outcomes; and 3) use
outcomes and achievements of the program goals to inform interventions to strengthen capacity and
performance of the Alliance. To achieve these aims, TEC will use the theoretical framework of logic models,
evaluation and management and implementation plans (MIPs), and Translational Science Benefits Model
(TSBM) to assess Alliance progress and outcomes; apply quantitative and qualitative research methods, CQI
methods, a centralized tracking and evaluation data repository, and innovative approaches such as Return on
Investment, and Social Network Analysis. TEC will also conduct formative and summative evaluations and
provide organizational development advice, coaching and initiatives. The innovation of TEC approaches will
mobilize core teams through an evaluation culture to successfully accomplish the mission of the Alliance and
make an original contribution of the best evaluation practices that can be applied to other multisite
infrastructure programs.